Vibrational Sensing in Super-Resolution Two-Dimensional Infrared Imaging

Project Summary
Vibrational Sensing in Super-Resolution Two-Dimensional Infrared Imaging
Many amyloidogenic peptides are implicated in diseases ranging from Alzheimer’s to diabetes to
cardiomyopathy. Chaperone proteins such as HSP27 and αB-crystallin serve a protective role by interacting
with amyloidogenic peptides to protect against amyloid diseases. However, amyloidogenic peptides such as
desmin fragments are susceptible to polymorphism, when the same peptide forms different amyloid
secondary structures, and it is not fully understood how this impacts the binding of chaperone proteins. We
hypothesize that chaperone proteins may interact with these amyloid polymorphs differently. Gaining a
fundamental understanding of chaperone-peptide interactions would lead to better targeted design strategies
for chaperone-fragment based drugs. However, we need a better tool set to understand the fundamentals of
chaperone-peptide interactions. Two-dimensional infrared (2DIR) imaging has the potential to transform
what we know about amyloidogenic peptide-chaperone interactions by revealing secondary structural
detail of a heterogeneous peptide and protein population. 2DIR is an ultrafast vibrational spectroscopy
technique sensitive to protein secondary structural changes and isotope labeling. Here, our goal is to
better understand how chaperones interact with amyloidogenic peptides and measure their changes in
secondary structure using improved 2DIR microscopy. In Aim 1, we will improve 2DIR microscopy spatially and
temporally to create the first ever super-resolution 2DIR microscope. These innovations will result in the first
ever super-resolution 2DIR microscope. Aim 2 will focus on bulk 2DIR measurements utilizing vibrational
sensing of isotope labeling to understand important peptide-chaperone contacts. 13C18O backbone labeling will
isolate regions or individual amino acids of peptides, and 13C segmental growth will isolate domains of
chaperone proteins. Our model system will investigate how chaperone proteins HSP27 and αB-crystallin
affect desmin peptide fragment aggregation in cardiomyopathy. We will also measure how domains
of HSP27 and αB-crystallin change structure during preventative contacts with desmin via isotope labeling
for vibrational sensing. This project will be the first to combine an isotope labeling approach with 2DIR
imaging to better understand peptide aggregation. This project will provide the first kinetic 2DIR data ever
distinguishing aggregating amyloid peptides from an added chaperone. Importantly, we can apply our 2DIR
bioimaging and isotope labeling strategies in collaboration with Research Project 3 of this COBRE for IR-
active modes of boron clusters and Research Project 4 for amyloid β-fibril investigations. Ultimately, this
Research Project will result in an entirely new bioimaging tool that can be applied to many future biophysical
protein questions.

Public health relevance
PROJECT NARRATIVE Project Narrative is not required in this component